FAM222A and amyloid plaque deposition in Alzheimer's Disease

PROJECT SUMMARY
Alzheimer's disease (AD) is the leading cause of dementia in the elderly, characterized by neurofibrillary
tangles, senile plaques and a progressive loss of neuronal cells in neocortex and hippocampus. Currently,
there is no effective treatment for AD. Less than 10% of AD cases are early onset with only a small fraction
caused by autosomal dominantly inherited genetic changes in APP, presenilin 1 (PS1) or presenilin 2 (PS2), all
of which are responsible for the overproduction of Aβ and the earlier formation of amyloid plaques. Though
more than 90% of AD cases are referred to as sporadic AD without family history, they have the similar clinical
and pathologic phenotypes as sporadic AD. Despite a large body of evidence suggests that Aβ deposition in
the brain as the likely culprit playing a critical role in the pathogenesis of AD or related dementia, the molecular
pathomechanisms of amyloid plaque formation remain largely elusive. Interestingly, in our recent study, we
have identified a novel protein Aggregatin specifically accumulated within the centers of amyloid plaques.
Aggregatin is predominantly expressed in the central nervous system and increased in brains of patients with
AD or amyloid precursor protein (APP) transgenic mice for AD. Excitingly, Aggregatin physically interacts with
Aβ with very high affinity, and remarkably facilitates Aβ aggregation even under near-physiologic nanomolar
concentrations. Forced expression of Aggregatin resulted in increased amyloid deposition, whereas ablation of
Aggregatin suppressed the formation of amyloid plaques in APP transgenic mice, further implying it as an
important factor for Aβ aggregating to form amyloid plaques. These exciting and promising preliminary studies
suggest that a detailed investigation into the potential role of Aggregatin in the formation of amyloid plaques in
AD is warranted. Using a novel transgenic mouse model with conditional ablation of Aggregatin, this study will
not only study whether and how Aggregatin regulates amyloid plaque formation and disease progression, but
also test the feasibility of targeting Aggregatin as a novel therapeutic approach for AD. Amyloid plaque is a
prominent common histopathological feature of in various major neurodegenerative diseases including but not
limited to AD. Our proposed studies of Aggregatin and its connection with amyloid plaque will have very broad
scientific and translational significance.

Public health relevance
NARRATIVE Alzheimer's disease (AD) is the most prevalent form of dementia in the elderly characterized by the appearance of amyloid plaques. Currently, there is no effective treatment for AD. Our study has identified Aggregatin as a novel protein specifically accumulated within the centers of amyloid plaques. Based on pilot studies showing the strong direct interaction between Aggregatin and amyloid-β peptide (Aβ), the remarkable ability of Aggregatin to facilitate Aβ aggregation, and importantly, the prevention of amyloid plaque formation by reducing Aggregatin, we will use a novel transgenic mouse model of Aggregatin to test whether Aggregatin could be a new therapeutic target for the treatment of AD and related dementia.